NCI-Frederick Operations and Technical Support II

Objectives of this project are to provide operational and technical support for the National Cancer Institute at Frederick. NIGMS is providing funding for the support of the GM/CA CAT Director's salary.